Profiling and Mapping Core

Profiling and Mapping Core B
Project Leaders: Kyu Rhee and D. Branch Moody
Co-investigators: Jacob Mayfield
ABSTRACT - Profiling and Mapping Core B
Modern infectious disease research relies fundamentally on genomic maps of the major pathogens. With the
recent development of whole-organism metabolomics profiling tools, comprehensively mapping the M.
tuberculosis (Mtb) metabolome is now feasible. Core B supports mass spectrometry-based profiling of Mtb
metabolites to support Projects 1, 2 and 3 that focus on discovery, drugs and diagnostics, respectively. The
Core will carry out whole-organism lipidomic and metabolomic profiling, archive datasets and use modern
bioinformatic methods to generate metabo-lipidomic maps of Mtb. Maps are comprised of a structured listing
of all metabolite subclasses, a list of all named metabolites within each class, and links of all named
metabolites to mass values and other biological variables. We previously generated the MycoMap Database,
which is the largest existing map of 183 mycobacterial metabolite classes linked to ~195,000 accurate mass
values. We will now expand the database by adding newly discovered lipids generated in Projects 1, 2 and 3.
Supporting Projects 1 and 2, we will solve the Mycolate Outer Membrane Lipid Map, which describes
compounds located at the host-pathogen barrier and involved in drug penetration. Supporting Projects 1 and 3,
the core will measure metabolite variation among Mtb strains from South African patients to generate the
Human Mtb Strain Lipid Variation Database. This database will describe the prevalence and variation of lipids
among strains circulating in human communities to identify lipids under control by host selection and to support
diagnostics development.